Core A - Administrative Core

CORE SUMMARY
The Administrative Core (Core A) is an essential core that will coordinate and provide appropriate
administrative support for all three projects and the other three cores in this PPG. The Core will provide
administrative support for the PI of this Core and the PPG (Dr. Dario Vignali) and will be located in Department
of Immunology at the University of Pittsburgh School of Medicine, Pittsburgh, USA.
In the first ~4 years of this program, Core A established a centralized and transparent organizational structure
to coordinate all scientific aspects of the PPG and resolve any conflicts or issues. We have increased the role of
the Core to promote training, education and collaboration among trainees. This Core will pursue two aims:
AIM 1: To provide collaborative and educational support for the program. Core A will continue to support
and promote collaborative and educational efforts by performing the following four key tasks. (1) Maintain IRPPG Box account. (2) Organize monthly meetings. (3) Promote education and training. (4) Coordinate annual
PPG retreat and ESAG.
AIM 2: To provide administrative support for the program. Administrative support and coordination will be
provided through seven key tasks. (1) Monitor progress on Projects and use of Cores. (2) Prepare noncompetitive renewal applications/progress reports. (3) Provide budgetary management and fiscal, regulatory,
and compliance oversight. (4) Coordinate resource sharing. (5) Authentication of key resources. (6) Verification
of manuscript submission to PubMed Central. (7) Conflict resolution.
PPG Interactions: Core A will work extensively with Projects 1, 2, and 3 to provide administrative and
organizational support, monitoring progress, and hosting data and presentations. The Core will also help
coordinate Cores B, C, and D by providing a platform for data sharing, monitoring usage and productivity, and
managing budgetary responsibilities. Lastly, it will organize meetings and retreats.

Public health relevance
CORE NARRATIVE The inhibitory receptors PD1 and LAG3 synergize to limit autoimmune disease. However, they are also over expressed in cancer and chronic viral infections, preventing disease clearance. Although PD1 and LAG3 are now major therapeutic targets, it is not clear how they mediated this synergistic regulation and on which cells types. A greater understanding of these issues could lead to move effective therapeutic strategies. Core A will provide administrative and statistical support to all projects and cores and is essential.